Microbiology Food Defense

PAR-20-105 Laboratory Flexible Funding Model (LFFM) (U19) Microbiology Discipline Analytical Track 1: Food Defense Track Division of Consolidated Laboratory Services Principal Investigator: Christopher Waggener, Ph.D. SF424: Other Project Information Project Summary: The Division of Consolidated Laboratory Services (DCLS) is the public health laboratory for the Commonwealth of Virginia and offers a wide variety of laboratory testing services for state and federal agencies, local governments and other states in support of public health, environmental protection and emergency response. DCLS provides surveillance and emergency response testing of food samples for the Virginia Department of Agriculture and Consumer Services (VDACS) Food Safety Program by offering nearly comprehensive testing of food samples by microbiology, chemistry and radiochemical methods. DCLS obtained ISO/IEC 17025 accreditation in January 2017 and has expanded this scope of accreditation to include currently nine test methods, and proposes to maintain and further expand this accreditation scope to include up to three new test methods during the budget period. DCLS’ experience with testing unknown food samples along with participation in FERN proficiency testing events, dedicated BSL-3 trained staff, dedicated laboratory space and equipment and our long standing history with the FERN Network sets DCLS apart from other state testing facilities. If granted these funds for food defense, DCLS is committed to providing emergency testing for any situation when called upon by the FDA. DCLS is also committed to providing testing support for national security events as well as participate in all FERN proficiency tests and training when applicable. DCLS will participate in FDA-requested exercises, and/or surveillance activities to support and maintain a state of readiness. In an effort to maintain a state of readiness, DCLS will ensure analysts are trained and have passed competency exercises, all equipment will remain in working order, and reagents and supplies are available or could easily or quickly be procured.

Public health relevance
PAR-20-105 Laboratory Flexible Funding Model (LFFM) (U19) Microbiology Discipline Analytical Track 1: Food Defense Track Division of Consolidated Laboratory Services Principal Investigator: Christopher Waggener, Ph.D. SF424: Other Project Information Project Summary: The Division of Consolidated Laboratory Services (DCLS) is the public health laboratory for the Commonwealth of Virginia and offers a wide variety of laboratory testing services for state and federal agencies, local governments and other states in support of public health, environmental protection and emergency response. DCLS provides surveillance and emergency response testing of food samples for the Virginia Department of Agriculture and Consumer Services (VDACS) Food Safety Program by offering nearly comprehensive testing of food samples by microbiology, chemistry and radiochemical methods. DCLS obtained ISO/IEC 17025 accreditation in January 2017 and has expanded this scope of accreditation to include currently nine test methods, and proposes to maintain and further expand this accreditation scope to include up to three new test methods during the budget period. DCLS’ experience with testing unknown food samples along with participation in FERN proficiency testing events, dedicated BSL-3 trained staff, dedicated laboratory space and equipment and our long standing history with the FERN Network sets DCLS apart from other state testing facilities. If granted these funds for food defense, DCLS is committed to providing emergency testing for any situation when called upon by the FDA. DCLS is also committed to providing testing support for national security events as well as participate in all FERN proficiency tests and training when applicable. DCLS will participate in FDA-requested exercises, and/or surveillance activities to support and maintain a state of readiness. In an effort to maintain a state of readiness, DCLS will ensure analysts are trained and have passed competency exercises, all equipment will remain in working order, and reagents and supplies are available or could easily or quickly be procured.